Technologies for Solid-State NMR Data Collection

TR&D 2 SUMMARY
The overall performance of the NMR spectrometer impacts every research sample and outcome. Often for
complex multidimensional magic-angle spinning solid-state NMR experiments, dozens of experimental
parameters require careful adjustment and must be readjusted anytime the environmental conditions drift. Here
proposed are approaches to accelerate the setup and configuration of such experiments to maximally leverage
the available instrument time, as well as to maintain performance over long periods of signal averaging that
can be required for precious research samples that are available only in limited quantity. All aspects of the
experimental performance also rely critically on the NMR probe designs, including the radiofrequency
electronic circuits and related interfaces to spin the sample, control the temperature and deliver homogeneous
pulsed magnetic fields as part of modern multidimensional NMR experiments.